The interplay of TIMELESS and PARP1 in DNA replication fork stability

ABSTRACT
We are requesting an instrument supplement to purchase an Incucyte S3 Live-Cell Analysis System from
Sartorius. Progress from the funded NIGMS R01 project for the past years has necessitated us implementing
the real-time and quantitative analysis of genome maintenance mechanisms in live cells. The Incucyte S3 allows
us to collect and analyze images of cell behaviors automatically and continuously in physiologically relevant
conditions. The specific applications relevant to the current project include, but are not limited to, real-time cell
cycle analysis, cellular proliferation, cell viability, and cell fate decision affected by the multiple mutants that we
have generated and under chemotherapy. The ability to monitor and image a variety of cellular processes
involved in DNA replication and stress responses under the real-time kinetics is crucial not only for the successful
completion of the parent R01 award but also for the new trajectories of research with a versatile and powerful
platform.

Public health relevance
NARRATIVE A versatile live-imaging platform will enable us to monitor and analyze the cellular processes involved in DNA replication and repair with unprecedented resolution. Better understanding on the mechanism of genome maintenance will promote our effort to exploit DNA replication problems of cancer cells for therapeutic intervention.